Non-invasive Therapy using Lamina Propria Extract for Vocal Fold Healing

PROJECT SUMMARY
To address the public health issue of voice disorders affecting approximately 20 million Americans annually due
to vocal fold (VF) scarring and laryngotracheal injuries, this project focuses on a non-invasive, innovative
treatment strategy. Utilizing a specially derived Vocal Fold Lamina Propria extract (VFLPx), which has
demonstrated promising results in reducing fibrotic gene expression, the proposed project aims to fine-tune the
dosage and application methods of VFLPx. The research is structured around three principal objectives: (1) To
conduct a detailed investigation into the anti-fibrotic and anti-microbial properties of VFLPx through advanced
proteomic analysis and targeted assays, identifying the key molecular constituents responsible for its therapeutic
effects. (2) To assess the efficacy of VFLPx in promoting wound healing within a rabbit model of VF injury,
exploring its use both as a singular treatment option and in conjunction with aerosolized forms, aiming to
minimize the reliance on invasive surgical interventions. This will include evaluating the benefits of both direct
injection and aerosolized delivery to determine the most effective approach for tissue repair. (3) To rigorously
evaluate the safety of nebulized VFLPx in a rat model, particularly its impact on lung function and the respiratory
system, to ensure its suitability for long-term use in human patients. The project’s ultimate goal is to establish a
solid foundation for developing a less invasive, more patient-friendly approach to treating VF and laryngeal
injuries, potentially revolutionizing the management of such conditions and significantly improving patient
outcomes.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project seeks to find a treatment for the 20 million Americans annually affected by voice disorders through the development of a vocal fold-specific extract (VFLPx), a noninvasive therapy aimed at reducing fibrosis and promoting healing in vocal fold injuries. The goal is to study the VFLPx’s anti-fibrotic properties and test it on animal models. Ultimately, this could alleviate the healthcare and societal burdens by updating voice disorder treatments and reducing the reliance on invasive procedures.